A novel platform for the discovery and characterization of migraine therapies

PROJECT SUMMARY
A major obstacle for the identification and characterization of new therapies for migraine and pain has been
limitations of the animal models used to study these therapies. We have developed a novel approach that
addresses this obstacle: a minimally invasive skull-attached microchip-based system and video
recording/analysis system that enables continuous recording and triggering of neurovascular activity and
behavior over months. We will further develop and validate this approach as a novel platform for the discovery
and characterization of migraine therapies. We will:
1. Quantify a comprehensive set of neurovascular and behavioral responses to established human
migraine triggers and cortical spreading depression (CSD) using the microchip/video platform.
2. Use the microchip/video platform to characterize the effects of acute migraine therapies on the
response to established migraine triggers and CSD to validate the platform as a useful tool for the
discovery and characterization of acute therapies
3. Use the microchip /video platform to characterize the effects of migraine preventive therapies.
Key findings will be independently replicated at two different institutions.
The platform described in this proposal represents a significant advance in our efforts to find new approaches
to the treatment of migraine, a highly prevalent and disabling nervous system disorder.

Public health relevance
Project Narrative This project will validate the use of a novel, minimally invasive, microchip/video recording system as a platform for testing migraine treatments. We will characterize the physiological and behavioral responses in 3 different migraine models and examine the effects of widely used acute and preventive migraine therapies on these responses. This platform will increase the accuracy and translational value of animal models for migraine for the discovery and characterization of new treatments.